Deciphering the immunologic landscape of Chagas cardiomyopathy pathogenesis

PROJECT SUMMARY/ABSTRACT
Chronic Chagas cardiomyopathy (CCC) is a devastating disease that develops in 30-40% of individuals
decades after initial infection with Trypanosoma cruzi, resulting in heart failure, cardiac arrhythmia, stroke,
pulmonary embolism, and sudden cardiac death. Currently, there is no effective treatment for CCC, there is no
way to predict which patients will go on to develop CCC, and the mechanisms that underly the disease
progression are very poorly understood. A better understanding of CCC pathogenesis is therefore urgently
needed to develop novel treatment strategies and allow for risk stratification of patients in need of personalized
interventions.
A compelling hypothesis to explain the pathogenesis of CCC centers around a hyperinflammatory
immune response that results in excessive cardiac damage over time. This study focuses on investigating how
B cells and their interactions with other cells can potentiate proinflammatory and autoimmune responses to
mediate the cardiac pathology seen in CCC. In the first aim, I will use a combination of high-throughput single-
cell RNA sequencing (scRNAseq) and spatial transcriptomics of human CCC samples to characterize the
immune pathways mediating CCC. Using scRNAseq on peripheral blood mononuclear cells from a longitudinal
cohort of patients that are known to develop CCC, I will characterize immune cell alterations that precede CCC
at a high resolution, potentially revealing early processes that mediate disease progression. Spatial
transcriptomics will be employed on end-stage human CCC heart tissue to determine the spatial association of
proinflammatory gene expression with regions of cardiac damage. This will help characterize the immune cell
subtypes and pathways that are most likely mediating direct tissue damage in human Chagas disease. Together,
these data will highlight potential therapeutic targets for both early and advanced CCC. The analyses of these
high-throughput sequencing experiments will have a strong focus on evaluating pro-inflammatory immune cells,
including B cells, and their signaling pathways. The second aim of this project seeks to determine whether B cell
depletion can provide a therapeutic benefit in a murine model of CCC. B cells will be depleted in two different
groups: 1) before cardiac manifestations develop, to evaluate the feasibility of immunotherapy for halting disease
progression; and 2) after cardiac manifestations have occurred, to evaluate whether targeted B cell depletion
can provide a therapeutic benefit in the advanced form of the disease.
Overall, the proposed study will transform our understanding of the immunologic mechanisms underlying
CCC pathogenesis. Long term, this work can serve to change the way in which we manage CCC, allowing us to
ultimately treat Chagas disease as an immunologic disorder rather than an infectious one. Long term, this work
will serve to inform strategies for diagnosis, prevention, and management of this important cardiac disease.

Public health relevance
PROJECT NARRATIVE Chagas disease is responsible for a considerable number of cases of cardiomyopathy, heart failure, and sudden cardiac death in the Latin American population. This work aims to better understand the mechanisms that mediate the progression towards these cardiac manifestations of disease that occur in 20-30% of individuals infected with the causal parasite. This project will focus on investigating the spatiotemporal alterations in the immune response that are associated with cardiac damage and will evaluate the therapeutic value of depleting B cells in a murine model of disease.